Environmental Exposures and the Development of Subclinical and Clinical Vascular and Myocardial Disease

PROJECT SUMMARY / ABSTRACT: Project 2
Environmental factors (i.e., ambient air pollution) are ubiquitous and potential causative factors in
cardiovascular disease (CVD). Our preliminary studies using data from the NIH-funded GeoHealth Hub and the
NHLBI-funded Center for cArdiometabolic Risk Reduction in South Asia Cohort (CARRS), indicate a strong
temporal association for short- and long-term effects of ambient particulate matter (PM2.5)) exposure and
elevated blood pressure and glycemic measures. Motivated by these findings, in Project 2 of Precision-
CARRS, we will investigate the longitudinal association between PM2.5 and CVD subclinical and clinical CVD
phenotypes (provided by the CVD Phenotyping Core). For atherosclerotic (ASCVD) and heart failure (HF)
pathways. Precision-CARRS, will follow 21,864 socio-demographically diverse South Asians aged ≥20 years,
representative of Delhi and Chennai, two cities with high levels of, and substantial spatio-temporal variability in,
ambient air pollution. The cohort will be followed for up to 15 years, accruing 176,536 person-years and >1000
incident ASCVD (MI, stroke, CVD death) events and nearly 940 HF Stage C/D cases. PM2.5 will be assessed
through a hybrid predictive model combining statistical and machine learning techniques using data from
satellites, land use maps, meteorology, and emissions inventories. Our aims are: To assess the relationship
between PM2.5 and: (Aim 1) Functional subclinical vascular and myocardial disease (arterial stiffness, and left
ventricular dysfunction measured as either systolic and/or diastolic dysfunction using echocardiography); (Aim
2) Structural subclinical disease (artery calcium; carotid intimal media thickness, carotid plaque); (Aim 3)
Clinical CVD events (i) ASCVD: incident nonfatal myocardial infarction, stroke, and CVD Death, (ii) HF: Stage
C/D cases). In Aim 4, we will explore whether the pathophysiologic pathway-specific proteins measured in
Project 1 (i.e., inflammation, immune dysregulation, myocardial ischemia and stress) modify the associations
between PM2.5 and clinical ASCVD and HF. We will also contribute data to Project 3 to further examine the
causal link between PM2.5 and CVD phenotypes using untargeted multi-omics, and Project 4 to separate social
from environment influences in the production of CVD risk. We will contribute to the understanding of the
connection between one of the leading adverse environmental exposures (i.e., air pollution) and CVD, to
improving precision of risk prediction by accounting for environmental factors to advance precision CVD
prevention, and generate data to facilitate global health policy to address air pollution.